CLINICAL EFFICACY OF VARIED TRANSFUSION REGIMENS IN THALASSEMIA MAJOR

This study tests of improved chelation with combined oral 2,3 dihydroxybenzoic acid and ascorbate supplements will permit intermittent subcutaneous administration of desferproxadine B and thereby prevent fatal congestive heart failure, a common, long-term effect of hemoglobing transfusion in these patients.